2025 Cilia, Mucus and Mucociliary Interactions Gordon Research Conference and Gordon Research Seminar

PROJECT SUMMARY
This application seeks support for a Gordon Research Conference (GRC) and corresponding Gordon Research
Seminar (GRS) on Cilia, Mucus and Mucociliary Interactions from February 16-21, 2025, in Pomona, CA. This
is a highly integrated and unique meeting that unites basic scientists, bioengineers, translational investigators,
and clinicians who study the components and fundamentals of cilia and mucus biology, their interface as a
mucociliary apparatus, and human diseases related to mucociliary dysfunction. Mucociliary clearance (MCC) is
essential for respiratory tract defense against inhaled pathogens. MCC dysfunction leads to infections and
complications in common conditions such as asthma through to rare genetic disorders, including cystic fibrosis
(CF) and primary ciliary dyskinesia (PCD). Advancing technologies have led to growing knowledge of the
assembly and function of cilia, the production and secretion of mucin glycoproteins, and the cilia-mucus
interactions required for MCC. These innovations stem from the ongoing work of established teams and new
entrants, including young investigators. Thus, a central element of this meeting focuses on promoting the visibility
of trainees and young investigators within the field, as well as championing women and minority researchers,
thus aligning with GRC and NIH missions. A cohesive program is proposed to enhance the interplay between
specialized disciplines that seek to integrate knowledge and impact advances in biochemistry, biophysics, cell
biology, development, genetics, and translational research of respiratory tract diseases. The GRS and GRC
leadership teams share a common vision of fostering an innovative, informative, and integrated forum for
discussing novel research and current challenges in mucociliary biology. The conference will emphasize the
following scientific themes: a) genetic and gene regulatory mechanisms of mucociliary components, b) structure
and function of mucin glycoprotein polymers and motile cilia, c) secretion of mucins and mechanics of ciliary
activity, d) the effects of mucociliary function and dysfunction on host physiology and pathophysiology, and e)
the on-going application of cilia and mucus biology to develop promote respiratory health and reduce the burden
of disease. With this approach, we seek to achieve three Specific Aims: 1) To disseminate, discuss, and integrate
the latest, unpublished, cutting-edge data on cilia, mucus and mucociliary interactions in a forum of world experts
and early career scientists; 2) to provide a platform that links fundamental scientific knowledge related to cilia,
mucus, and mucociliary interactions to human disease and avenues for diagnosis and therapies; and 3) to
facilitate and promote the involvement and advancement of underrepresented minorities, women, and trainees
across aspects of mucociliary interactions, through top-down program choices to increase global representation,
as well as bottom-up initiatives including childcare grants and Carl Storm fellowships to mitigate barriers to more
inclusive audiences.

Public health relevance
PROJECT NARRATIVE This unique, multidisciplinary conference brings together world experts to discuss the very latest research related to the biology and clinical aspects of mucus and cilia, hair-like structures on the surface of airway epithelial cells, as well as their interactions to create effective mucociliary clearance. The overarching goal of this meeting is to provide an opportunity for senior scientists in the field to interact with junior, female, and underrepresented minority scientists, facilitating the discussion of the genetic, developmental, and diagnostic features of respiratory tract diseases in children and adults (such as common conditions including asthma, as well as rare genetic disorders such as cystic fibrosis and primary ciliary dyskinesia), leading the way to new treatments and offering a unique environment conducive to collaborations and solutions for this global challenge.